NARCH XI White Mountain Apache Tribe (WMAT)- Johns Hopkins University (JHU) Administrative Core

PROJECT SUMMARY:
The goal of the NARCH XI White Mountain Apache Tribe (WMAT)- Johns Hopkins University (JHU)
Administrative Core is to coordinate functions across the 4 NARCH projects proposed in this application,
including: 1) a Student and Faculty Development project that will integrate academic and field-based research
training, and 2) three NARCH research projects to: a) address the large burden of Staphylococcus aureus
infections; b) reduce binge drinking and drug use among White Mountain Apache youth , and c) improve breast
cancer screening and, ultimately, stage of diagnosis and survival among White Mountain Apache women.
Core administrative functions will include the following: Management and facilitation of the NARCH XI
Community Advisory Board; Coordination of communication among proposed Student/Faculty and Research
components; Oversight of federal reporting and fiscal management responsibilities; Oversight of data safety
and monitoring; Oversight of confidentiality protections; Oversight of evaluation and long-term strategic
planning; Continuous development of resources and strategies to expand and sustain the training, mentoring
and research initiatives; Dissemination of information on NARCH training and research progress to tribal
members and leaders; allied agencies addressing tribal health and well-being, and the national and global
scientific community.

Public health relevance
PROJECT NARRATIVE: NARCH XI will build on the successful partnership between WMAT and JHU to advance the tribe's sovereignty in health research and education. We are creating a future where community members will lead our health agencies and research agenda. NARCH has been a way to change research from a tool that once exploited Native people to an agent of change for future health and well-being.